Localized small molecule delivery to improve tendon-to-bone integration following anterior cruciate ligament reconstruction

Anterior cruciate ligament (ACL) injuries are one of the leading causes of training and sports related injuries and
contribute to post-traumatic osteoarthritis. Torn ACLs are commonly reconstructed, instead of repaired, utilizing
a tendon graft that is passed through bone tunnels created in the femur and tibia positioned at the native ACL
footprints. Even with advancements in surgical technique and rehabilitation strategies, graft failure and recurrent
knee instability are unfortunate complications. Additionally, rehabilitation following surgery is critical to a
successful outcome, with premature return to activity resulting in an increased risk of graft failure and reinjury.
Consequently, there is an unmet clinical need to improve and expedite treatment of these debilitating injuries, to
get patients back to their active lifestyles while minimizing the risk of graft failure. Recreating the zonal tendon-
to-bone insertion site (i.e., enthesis) is critical to restoring normal function following these injuries. Zonal enthesis
formation involves anchoring collagen fibers, synthesizing proteoglycan-rich fibrocartilage, and mineralizing this
fibrocartilage. The hedgehog (Hh) signaling pathway is critical to the formation of this zonal insertion during
growth and development by promoting the formation of unmineralized and mineralized fibrocartilage zones of
the enthesis. Recent studies by our group demonstrate that this pathway has a similar role in producing
fibrocartilage within zonal attachments in the bone tunnels following ACL reconstruction. Therefore, our long-
term goal is to develop therapies that leverage this pathway to improve repair outcomes and expedite recovery.
The objective of this proposal is to locally deliver a small molecule Hh signaling agonist to increase the formation
of zonal tendon-to-bone attachments. We will conduct an extensive in vitro release study to test the duration and
bioactivity of SAG released from our innovative BiLDS scaffolds in Aim 1. We will then translate this novel delivery
system to treat NZW rabbits following ACL reconstruction in Aim 2 via localized delivery of the agonist in the
bone tunnels. Our hypothesis is that delivery of the agonist will stimulate the local progenitor cells to proliferate
and then differentiate into fibrochondrocytes in the attachments. To test this hypothesis, in Aim 2, we will assess
the extent of tunnel integration by measuring proliferation of the progenitor pool, zonal attachment formation via
mineralized cryo-histomorphometry, and integration strength via anterior-posterior drawer and uniaxial
mechanical testing. Additionally, we will determine the long-term effects of agonist release on joint health by
measuring changes to the synovium and articular cartilage. Finally, we will use activity monitoring post-surgery
and longitudinal in vivo MRI imaging to track the animal rehabilitation and healing response. Successfully
harnessing the Hh pathway therapeutically could result in a paradigm shift in treatment of these debilitating
injuries and could also more broadly inform future tendon-to-bone healing therapies.

Public health relevance
Anterior cruciate ligament (ACL) injuries are a leading cause of training and sports-related injuries, resulting in significant loss of activity and quality of life. ACL reconstruction, a common treatment, requires suitable tendon graft-to-bone integration to resume prior activities, as such there is an unmet clinical need to improve and expedite treatment of these debilitating injuries to get patients back to their active lifestyles and minimize health care expenditures. This proposal seeks to address this clinical need by localizing delivery of a small molecule agonist of the hedgehog pathway, a potent regulator of fibrocartilage formation during enthesis development, to improve tendon-to-bone integration following anterior cruciate ligament reconstruction.